The Neural Mechanisms of Winner and Loser Effect

ABSTRACT
Aggression is an important social behavior widely observed across species, including humans. It is
considered an innate behavior because its expression requires no learning. With the right sensory
trigger, often one associated with conspecific competitors, aggression is expressed as a series of
stereotyped motor actions. However, the readiness to express aggression, or aggressiveness, varies
widely among individuals. Experiences of winning and losing are known to contribute to this individual
variability. Winning leads to an increase in aggressiveness while losing decreases aggressiveness, a
phenomenon termed the winner and loser effect. While key hormonal events accompanying winning
and losing have been identified, the neural mechanisms underlying the winner and loser effect remain
poorly understood. We hypothesize that the aggressiveness of an individual is determined by the
efficiency of sensory-motor transformation of the aggression circuit, which is determined by the
biophysical properties and synaptic transmission of cells in the circuit. Winning and losing experiences
alter the excitability and/or communication of aggression-related cells and ultimately changes the
readiness to attack. Leveraging upon our deep understanding of the aggression circuit in male mice, in
this study we will test this hypothesis through three specific aims. First, we will simultaneously record
the aggression-cue evoked in vivo neural responses and glutamatergic release from 13 brain regions
along the sensory-motor pathway that mediates aggression and examine the response changes over
repeated winning and losing experiences. Second, we will use in vitro patch clamp recording to
investigate the intrinsic properties and synaptic transmission of aggression-related cells from animals
with repeated winning, losing and social interaction experiences. Our preliminary results revealed that
the aggression circuit undergoes two-stage plasticity, first synaptic plasticity and then cellular plasticity,
over repeated winning. Following up on this initial finding, in Aim 3, we will address the contribution of
synaptic plasticity to short- and long-term winner and loser effect and the induction of cellular plasticity.
The significance of our study is that it addresses a fundamental neuroscience question -- how social
experience alters the brain to influence innate behaviors. It will also provide new understanding
regarding the neural mechanisms underlying individual variability in aggressiveness. Such
understanding could ultimately lead to novel strategies for treating psychiatric patients suffering from
exaggerated aggression.

Public health relevance
PROJECT NARRATIVE Violence imposes huge risk to our society and our inability to control excessive aggression stems from our ignorance of its generation and modulation. The goal of our study is to understand how social experiences alter the brain’s aggression circuit and lead to changes in aggressive behaviors. A better understanding of the neural underpinnings of natural variation in aggression may lead to novel strategies to specifically treat excessive aggression.